Cerebral endothelial cells derived exosomes as a therapy for cognitive impairment in aged diabetic rats

Abstract:
Diabetes mellitus (DM) induces cerebral vascular dysfunction and impairs the hippocampal neurogenesis,
resulting in cognitive decline. Cerebral angiogenesis couples with neurogenesis. Molecules that mediate the
interaction between cerebral endothelial cells and neural stem cells in particular in DM have not been fully
investigated. Cerebral endothelial cells constitutively release exosomes, which mediate intercellular
communication. Our preliminary data demonstrated that exosomes derived from dysfunctional cerebral
endothelial cells of DM rats communicate with neural stem cells and inhibit neurogenesis. Importantly,
administration of exosomes isolated from cerebral endothelial cells (CE-exo) of healthy adult brain to DM rats
robustly improved cognitive function and minimized DM-induced cerebral endothelial cell dysfunction and DM-
impaired hippocampal neurogenesis. In this application, we therefore, propose to develop cerebral endothelial
exosomes as a mechanism-based therapy for DM-induced cognitive decline in the aged rats. There are three
Aims. Aim 1 tests the hypothesis that CE-exo treatment reduces cognitive deficits in the DM rat. Aim 2 tests
the hypothesis that CE-exo treatment improves cerebral vascular patency and integrity, and promotes
neurogenesis in the aged-DM rat. Aim 3 tests the hypothesis that engineered exosomes carrying elevated
selective miRNAs have enhanced effects on cerebral vascular function and neurogenesis as well as cognitive
function. These studies will provide preclinical evidence for developing CE-exo as an innovative treatment for
DM-induced cognitive dysfunction.

Public health relevance
Narrative: Diabetes mellitus accelerates cognitive decline in the growing aging population, and thus, development of specific therapeutic strategies to address DM induced cognitive impairment is of major clinical importance. Exosomes are naturally occurring nano extracellular vesicles that mediate intercellular communication by transferring their biomolecule content to recipient cells. Our preliminary data suggest that healthy cerebral endothelial cell-derived exosomes have potential for improving cognitive function in the aged DM rats. We therefore propose to develop a novel exosomes based therapy for DM-induced cognitive dysfunction.